Ohio Kentucky Pancreatitis Research Center (OKPRC) to advance the diagnosis and treatment of chronic pancreatitis

Project Summary / Abstract
The mechanistic underpinnings of diseases involving the exocrine pancreas are poorly
understood. Chronic pancreatitis is often accompanied by inflammation of the pancreas,
irreversible fibrosis, and destruction of the pancreatic parenchyma resulting in abdominal pain,
malnutrition, exocrine pancreatic insufficiency, diabetes, and, in some cases, pancreas cancer.
Our Clinical Center (Ohio Kentucky Pancreatitis Research Center (OKPRC)) is interested in
continuing our efforts to continue leading and supporting the research infrastructure of the
Chronic Pancreatitis Clinical Research Consortium to conduct longitudinal clinical research to
address the many knowledge gaps related to chronic pancreatitis. We propose a series of
hypothesis driven studies to: 1) validate the use of a novel biomarker for diagnosis of
chronic pancreatitis, 2) understand nutritional and metabolic alterations in chronic
pancreatitis, and 3) advance clinical trials for chronic pancreatitis. First, we aim to
complete a phase 2 (validation) biomarker study of circulating NGAL for diagnosis of chronic
pancreatitis, considering applications to both rule-in and rule-out the disease. In regard to
nutritional alterations, we will conduct novel analyses of dietary patterns in participants with
chronic pancreatitis to identify associations with disease-related complications and identify
potential opportunities for a dietary intervention. We will extend initial analyses regarding the
use of a pancreatic hormone (pancreatic polypeptide) as a diagnostic marker of diabetes in the
setting of chronic pancreatitis. We will also evaluate for genetic risk in chronic pancreatitis for
the development of osteopathy. Lastly, we describe two clinical trials that are in progress to
illustrate the strengths of our collaborative team, and opportunities to improve the efficiency of
future clinical trials. Altogether, we aim to contribute to the collaborative environment of the
Consortium to accomplish these (and other) studies to improve our ability to diagnose and treat
chronic pancreatitis.

Public health relevance
Narrative Chronic pancreatitis is associated with inflammation and fibrosis of the pancreas that can lead to sequelae including abdominal pain, diabetes, exocrine pancreatic insufficiency, osteopathy, and pancreas cancer. Physicians need accurate tests to better diagnose patients with suspected chronic pancreatitis and identify those with pancreatogenic diabetes before end- organ damage or cancer develops. The Ohio Kentucky Pancreatitis Research Center (OKPRC) will join other Clinical Centers in the Chronic Pancreatitis Clinical Research Consortium (U01) to leverage their collective experience and research infrastructure to further understand how to diagnose and treat chronic pancreatitis and its sequelae.